Establishment and Modulation of DNA Methylation Patterns in Arabidopsis

Abstract
Within any given organism, each cell has essentially identical genetic material, yet not all cells behave similarly.
One source of this remarkable diversity is the presence of chemical tags, like DNA methylation, that decorate
the genome and play roles in diverse biological processes including gene regulation, transposon silencing, and
imprinting. While it is known that the patterns of DNA methylation can differ between tissues or cell types, how
such patterns are generated and how they influence gene expression patterns remain poorly understood. As
aberrant DNA methylation patterns are associated with developmental defects in plants and with numerous
diseases in humans, understanding these aspects of epigenetic regulation are of critical importance.
Using the plant model, Arabidopsis thaliana, the lab recently discovered a family of four related chromatin
remodeling factors that control DNA methylation patterns in a locus- and tissue-specific manner. Based on new
insights gained during the characterization of these chromatin regulators, this proposal seeks to understand the
mechanisms that facilitate the locus-specific targeting of DNA methylation, to determine the checks and balances
that enable genome-scale homeostasis within methylation pathways, and to investigate how genetic and
epigenetic inputs are integrated to regulate DNA methylation patterns. Addressing these aspects of epigenetic
regulation will not only be important for understanding the roles of DNA methylation during normal growth and
development, but they will also provide insights into the causes and consequences of dysregulation within DNA
methylation pathways.
Arabidopsis thaliana is an ideal system to study epigenetic processes, like DNA methylation, as it is genetically
malleable, has a small genome that is highly amenable to genome-wide analyses, and is tolerant of dramatic
changes in its epigenetic landscape. In addition, many of the key players and pathways involved in establishing,
maintaining, and reading epigenetic modifications are conserved between plants and mammals. Given these
similarities, findings regarding how specific methylation patterns are generated and modulated during
development, will be applicable to analogous processes in mammals.

Public health relevance
Project Narrative Modifications to DNA and histones, the two main components of chromatin, alter the landscape of the genome and play critical roles in facilitating normal growth and development. Among these modifications, aberrant DNA methylation patterns are associated with numerous developmental defects and diseases, yet how specific patterns of methylation are generated and how they are modulated during development, or in response to the environment, are poorly understood. To address these questions, this proposal focuses on characterizing the functions and locus-specificities of chromatin remodeling factors and other transcriptional regulators that are critical for establishing DNA methylation patterns and regulating gene expression.